Therapeutic modulation of tissue nonspecific alkaline phosphatase activity in acute inflammation and sepsis

PROJECT SUMMARY
The goal of this application is to evaluate the role of tissue nonspecific alkaline phosphatase activity in cerebral
microvessels as a therapeutic target to protect against sepsis-associated neurological impairment. Sepsis is
defined as a dysregulated host response to infection that results in multi-organ dysfunction. One organ that is
commonly affected in sepsis is the brain. Acute brain dysfunction observed in sepsis patients frequently results
in chronic functional and cognitive neurological deficits in sepsis survivors. However, therapeutic approaches to
prevent or ameliorate sepsis-associated neurological deficits are limited. Preliminary data from our laboratory
demonstrates that TNAP, an enzyme that is highly enriched in cerebral microvessels, may reduce neurological
deficits by protecting against the loss of blood-brain barrier (BBB) integrity. We have shown the loss of TNAP
activity in cerebral microvessels is coupled with increased vascular permeability, increased leukocyte infiltration
into the brain, loss of junctional proteins, and sustained glial activation. The loss of BBB integrity is one of the
key events in the pathophysiology of sepsis that is thought to initiate subsequent neuroinflammatory events
which result sepsis-associated neurological deficits. In addition, a stable, recombinant alkaline phosphatase
(recAP) is currently in clinical trials for treatment of acute kidney injury in sepsis. Taken together, this evidence
suggests that recAP may protect against chronic functional and cognitive deficits in sepsis survivors. This
application will investigate the central hypothesis that administration of recAP protects against sepsis-associated
neurological impairment by protecting BBB integrity and preventing functional and cognitive deficits. To test this,
we will use an established preclinical model of experimental sepsis, cecal ligation and puncture (CLP), to
determine the optimal therapeutic dose of recAP that will suppress functional and cognitive deficits and prevent
the loss of BBB integrity. Male and female mice (8-10 months old) will be subjected to sham- or CLP- surgery
and randomly allocated to vehicle or recAP treatment; this will be followed by behavioral testing and subsequent
assessment of BBB integrity after 7 days or 28 days. Aim 1 will evaluate recAP as a potential therapeutic strategy
to prevent sepsis-associated functional and cognitive deficits. Functional deficits to be assessed are
spontaneous and evoked locomotion, gait impairment, and nociception, while cognitive testing will assess
associative and reference memory deficits. Aim 2 will determine the ability of recAP to preserve BBB integrity in
sepsis. Vessel permeability, junctional proteins, actin cytoskeleton remodeling, and glial activation will be
quantified in cortex and hippocampus. The expected outcomes of this exploratory application will provide a
foundation for future mechanistic preclinical studies of a novel therapeutic target (TNAP) and a novel therapeutic
drug (recAP) to improve neurological outcomes in sepsis.

Public health relevance
PROJECT NARRATIVE Sepsis is life-threatening disorder caused by an unregulated systemic response to an infection. Sepsis survivors often experience chronic functional and cognitive deficits, yet there no targeted therapies to prevent the onset, progression, or severity of these symptoms. This proposal will test whether a protein that resides on brain microvessels is a viable therapeutic target to prevent chronic neurological impairment in sepsis survivors.